Testing Novel Pharmacogenetic and Adherence Optimization Treatments to Improve the Effectiveness of Smoking Cessation Treatments for Smokers with HIV

The advent of anti-retroviral therapy (ART) for people living with HIV/AIDS (PLWHA) substantially improved life
expectancy but, now, PLWHA who smoke lose more life-years due to tobacco use than they do to their HIV
infection. Unfortunately, the rate of smoking among PLWHA in the US is about 40%. The limited tobacco use
treatment research with PLWHA indicates that behavioral treatments and medications (nicotine patch and
varenicline) yield moderate effects on cessation, with quit rates that are considerably lower than they are for the
general population. Thus, there is a critical need to identify novel ways to optimize tobacco cessation treatment
for smokers with HIV. Two factors are highly predictive of cessation outcomes with pharmacotherapy, in the
general population and among PLWHA. First, a smoker's rate of nicotine metabolism, characterized by the
nicotine metabolite ratio (NMR, a marker of CYP2A6 gene variants), predicts cessation both for varenicline and
nicotine patch. Our studies with general population and HIV-infected smokers show that personalizing the choice
of medications for smokers using the NMR can increase efficacy and reduce toxicities, an approach highlighted
by the NCI (https://www.cancer.gov/about-nci/budget/plan/public-health). Second, adherence to smoking
cessation medications, in the general population and among PLWHA, rarely exceeds 60% and non-adherence
lowers cessation rates 2-3 fold. We developed the Managed Problem Solving (MAPS) intervention which is
endorsed by the CDC (https://www.cdc.gov/hiv/research/interventionresearch/compendium/ma/index.html) as
an evidence-based intervention for medication adherence among PLWHA. Thus, the application's premise is
that incorporating intervention components to tailor tobacco use medications (varenicline or patch) with the NMR
and increase adherence to the medication using MAPS will optimize tobacco treatments for PLWHA. To test this
premise, we will conduct a rigorous multi-site randomized clinical trial with 488 HIV+ smokers to evaluate
NMR-tailored treatment and MAPS as optimization strategies for tobacco dependence treatment for PLWHA.
We will use a factorial design to examine: 1) The effects of the NMR-tailored and/or MAPS interventions on end-
of-treatment (EOT) and 6-month smoking cessation rates (primary aim); 2) Mediators of the NMR-tailored and
MAPS interventions (secondary aim); and 3) Moderators of the NMR-tailored and MAPS interventions
(exploratory aim). Our overall approach is consistent with the Multiphase Optimization Strategy which has gained
prominence for guiding the evaluation of interventions for enhancing tobacco use treatment effectiveness.
Addressing these aims will determine: the use of adherence and pharmacogenetic optimization of smoking
cessation treatment for PLWHA, the mechanisms that underlie the effects of these optimization strategies on
cessation outcomes, and the variation in the effects of these optimization strategies across sub-groups of
PLWHA. In the end, this trial will help understand if getting the right medication to the right person and helping
to make sure they sufficiently use that medication optimizes tobacco cessation treatment for this population.

Public health relevance
Smoking among PLWHA is a critical public health issue, with the rate of smoking 2-3 times greater than it is in the general population and the health risks of smoking outweighing those associated with the virus itself. Unfortunately, remarkably few studies have evaluated smoking cessation interventions for PLWHA and the available literature indicates that both behavioral and pharmacological smoking cessation interventions yield modest effect sizes and quit rates that are considerably lower than in the general population. A sizable literature, including studies by our research team, indicates that using the nicotine metabolite ratio (which represents the speed at which smokers metabolize nicotine; NMR) to personalize the selection of medications for tobacco use and the MAPS intervention to augment adherence to these medications can optimize treatments for tobacco use among PLWHA. As such, this trial will test these intervention optimization strategies to determine if individually or together these interventions can represent an effective approach to treating tobacco use in this population of smokers. As a major advance for this area of work, we will use rigorous methodology to evaluate these optimization strategies (i.e., a randomized design, biological verification, an ITT approach, and 6-month outcome assessments) and, overall, our approach is consistent with the MOST framework, which has been used to identify intervention components that maximize cessation outcomes. This trial will also assess theoretically derived and empirically based mechanisms through which these optimization strategies affect cessation and explore sub- groups who are more or less responsive to these strategies. In the end, this trial will determine if getting the right medication to the right person and helping to make sure they adequately use the medication optimizes tobacco cessation treatments among PLWHA in order to improve health outcomes for this population.